Long-range GABAergic inhibition coordinates hippocampal-subcortical circuit activity in memory formation

PROJECT ABSTRACT
The hippocampus is vital for spatial navigation, learning and memory, and is extensively interconnected with
many cortical and subcortical regions. In addition to the well-defined long-range glutamatergic projections,
emerging evidence suggests that a diverse group of GABAergic inhibitory neurons can also send long-range
projections to distant areas. This long-range inhibition is ideally positioned to synchronize rhythmic activity and
coordinate cell ensemble activity of multiple brain areas to participate in various behavioral tasks. One such
example is theta oscillations – a 4-12 Hz rhythmic activity important for memory encoding and retrieval.
However, despite the potential importance of the long-range inhibition in coordinating activity between the
hippocampus and other brain regions, its cell identity, electrophysiological properties, connectivity, and
behavioral roles remain poorly understood. In our preliminary experiments, we performed anterograde tracing
to demonstrate that somatostatin-expressing, but not parvalbumin-expressing, inhibitory neurons in the
hippocampal CA3 region project to two subcortical areas known as pacemakers for theta oscillations – medial
septum-diagonal band of Broca (MS-DB) and supramammillary nucleus (SUM) in the hypothalamus. Ex vivo
ChannelRhodopsin2 (ChR2)-assisted patch-clamp recordings further revealed that these long-range inhibitory
neurons preferentially inhibit presumptive GABAergic and glutamatergic neurons in MS-DB and GABAergic
neurons in SUM, and optogenetic stimulation of somatostatin-expressing axons robustly entrained firing of
postsynaptic MS-DB neurons at theta frequencies. We, therefore, hypothesize that somatostatin-expressing
inhibitory neurons in CA3 send long-range projection to coordinate cell ensemble activity of CA3, MS-DB and
SUM during theta oscillations. In this proposal, we will perform intersectional viral-based neural tracing and ex
vivo brain-slice patch-clamp recordings to define anatomical connectivity and cellular and synaptic properties
of long-range projecting somatostatin-expressing neurons, and determine their functional connections with
both local and remote target regions. Furthermore, we will employ in vivo electrophysiology, closed-loop
optogenetic stimulation, and behavior analysis to determine whether these long-range somatostatin-expressing
inhibitory neurons play a role in coordinating activity between the hippocampus and MS-DB or SUM in memory
formation. As abnormalities in coordination and synchronization between the hippocampus and other brain
areas have been implicated in numerous brain disorders, such as Alzheimer’s disease, schizophrenia, and
major depression, the proposed studies will not only deepen our understanding of physiological functions of
hippocampal long-range inhibition, but also provide a knowledge base for future studies to examine the role of
long-range inhibition in these diseases.

Public health relevance
PROJECT NARRATIVE The proposed research aims to determine the cell identity, electrophysiological properties, and functional connectivity of hippocampal long-range projecting GABAergic neurons, and examine whether this long-range inhibition coordinates and synchronizes activity between the hippocampus and subcortical regions in memory formation. Given that impairments of coordination and synchronization between the hippocampus and other brain areas have been implicated in a number of neurological and psychiatric disorders, such as Alzheimer’s disease and depression, the knowledge gained from this proposal will provide new insights into both normal functions of hippocampal-subcortical circuits and their potential involvement in diseases.